Enhance the security and resilience of the national food safety system

Abstract
This grant proposal from the University of Arizona, Arizona Veterinary Diagnostic Laboratory is in response to
Funding Opportunity Announcement (FOA) # PAR-22-063 from the Food and Drug Administration’s (FDA)
Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response
Network (Vet-LIRN).
The purpose of this proposal from University of Arizona, Arizona Veterinary Diagnostic Laboratory (AzVDL) is to
address the following three key project areas:
1. Participation in FDA/Vet-LIRN surveillance assignments and sample analysis in the event of animal food or
drug-related illnesses or other large-scale animal food/drug emergency events requiring surge capacity testing
of implicated diagnostic or animal food samples.
2. Providing analytical data using standardized methods, equipment platforms, and reporting methods;
participation in proficiency testing and method training provided by the Vet-LIRN Program Office (VPO) at the
Center for Veterinary Medicine; and implementation of standardized quality management systems for
laboratories.
3. Participation in small-scale method development, method validation and/or matrix extension work as
determined by the VPO. A successful implementation of the project outlined in the proposal is predicted for many
reasons including the extensive experience of AzVDL’s professional and technical staff. The qualifications of the
technical and professional staff are presented. As part of the proposal, a detailed view of the laboratory facilities
and quality system are provided.
This grant proposal also addresses the CVM request for sample analysis commitment as well as the laboratory’s
ability and willingness to complete the proposed research in a timely manner. Several additional documents
including the internal Proficiency Testing (PT) results (see Research Strategy), and certificate of AAVLD
accreditation (appendix of Research Plan) are provided along with the

Public health relevance
Project Narrative PAR-22-063 FOA is to solicit applications for inclusion into the FDA's Veterinary Laboratory Investigation and Response Network Cooperative Agreement Program (LIRN). The AzVDL has been a member of the NAHLN Network for 20 years and has the staff, experience, equipment and facilities to contribute to the LIRN.